Aerosol Ventilation for Rapid Cooling of Transplant Donor Lungs

PROJECT SUMMARY
Over 2,700 lung transplants are performed in the US each year, but a significant shortage of
donor lungs means that thousands of people die each year while waiting for a suitable donor
organ. Although most donor lungs in the US are currently taken from brain-dead donors, only
~20% of multiorgan brain dead donors provide suitable lungs for transplantation. A significant
opportunity for more donor lungs lies with donation after cardiac death (DCD) donors, but only a
tiny fraction of DCD donors in the US are used for lung transplantation due to concerns over
ischemic damage. Lungs are considered significantly injured from warm ischemia if they are not
cooled and oxygenated within 60–90 min of diminished perfusion or oxygenation. In addition,
lungs from DCD donors subject to warm ischemia for >60 min prior to procurement have
impaired bronchial healing and greater risk of primary graft dysfunction or reperfusion injury. As
such, developing a simple and non-invasive method of cooling and oxygenating lungs in
potential uncontrolled DCD donors would mitigate the damaging effects of warm ischemia while
the donor is prepared for procurement and provide a boundless supply of lung donors from this
untapped donor pool.
To improve the pool of usable donor lungs, Boundless Science, LLC developed a bi-liquid
aerosolized ventilation (BAV) device prototype that cools a lung quickly and efficiently following
death. The BAV aerosolizes a mixture of two liquid perfluorocarbons (LP), introduces the
atomized droplets into the lungs through a ventilator or mask, collects evaporated LP vapors
from the lungs, condenses and oxygenates the vapor, and returns the cooled LP liquid to the
lungs via the original aerosolization method. The LP’s enthalpy of vaporization provides rapid
cooling while its ability to carry oxygen prevents hypoxic lung damage. This safe, easy-to-use,
portable device is ambulatory and can be used in the ICU and the ER to non-invasively cool and
oxygenate lungs for transplant well within an hour after death.
The objective of this phase 1 proposal is to provide proof of concept that lungs can be efficiently
cooled from 37°C to 20°C (to decrease metabolic consumption by the lungs while providing
oxygen to the airways) in <30 min using a combination of LPs. To achieve efficient cooling with
BAV, we believe that we need to incorporate the following optimized parameters: droplet size
and their alveolar dwell time, boiling point of the LP mixture, and heat transfer fluid. This will be
achieved using four Specific Aims. Aim 1: Create the optimal droplet size and density to
effectively infiltrate alveoli with aerosolized Perfluoropentane. Aim 2: Build and evaluate an
exhaled cooling system to recover the vaporized LP. Aim 3: Determine the optimized mixture of
LPs and a clinically relevant cooling method such that pig lungs can be cooled by 17°C (to
20°C) in under 30 minutes using optimized BAV parameters. Aim 4: Modify ventilator settings to
manipulate the alveolar dwell time of LP droplets. Once proof of concept has been obtained, we
will progress to Phase II, where we will refine our prototype device, test it on live animals and
test for tissue health, and pursue FDA approval.

Public health relevance
PROJECT NARRATIVE Thousand of patients die each year while waiting for a lung transplant because of a scarcity of suitable donor lungs, in part because of the challenges associated with the rapid cooling and oxygenation necessary to prevent transplant-preventing lung injury after the death of a potential donor. To solve this issue, we have developed a system (termed bi-liquid aerosolized ventilation device) to efficiently and rapidly cool and oxygenate lungs before any damage occurs, thereby having the potential to significantly increase the pool of donor lungs. Our portable device is safe, easy-to-use, and ambulatory, and can be used in the ICU and the ER to non-invasively cool and oxygenate lungs for transplant well within an hour after death.